Research and Methods Core

RESEARCH AND METHODS CORE: PROJECT SUMMARY
The Research and Methods Core (RMC) will drive the application of innovative methodologic solutions to
the challenges of implementing evidence-based interventions for the prevention of cancer among people living
in persistent poverty. The central goal is achieving reach through equitable implementation to meet the needs
and resources of delivery systems that serve youth, families, and individuals in areas of persistent poverty. The
RMC will support the research activities of “HOPE & CAIRHE 2gether” (HC2) through three specific aims:
Aim 1: INNOVATE: Serve as a hub for cross-project methodologic synergies to advance cancer prevention
implementation science in persistent poverty areas. The RMC will ensure proper application of novel
implementation research tools while highlighting unique methodologic advancements facilitated by HC2's
collaborative structure. Central to this aim are innovations facilitated by three methods developed by RMC Co-
Lead Smith: (1) the Implementation Research Logic Model; (2) an implementation outcomes common data
elements tool; and (3) a novel and rigorous system for longitudinal tracking of implementation strategies and
their dynamic modifications over time. Aim 2: SUPPORT: Ensure methodologic support for HC2 research
activities. The RMC will ensure that HC2's Research and Pilot Projects have excellent methodologic support to
carry out their specific aims and those of HC2 overall. Specifically, the RMC will identify common data
elements, orchestrate the use of shared measures, and provide rigorous quantitative, qualitative, health
economic analyses and implementation science methods across the Research and Pilot Projects. We will use
quantitative, qualitative, and mixed methods approaches to answer each project's stated specific aims as well as
novel and convergent research questions that emerge through HC2's work. Aim 3: EVALUATE: Measure HC2
research productivity and impact. The RMC will collaborate with the Administrative Core to measure and
evaluate HC2's progress toward achieving research and training milestones and outcomes. We will use the
Translational Science Benefits Model to demonstrate the impact of our work in the real world on metrics
salient to HC2 and the Persistent Poverty Initiative (RFA-CA-22-015).
The RMC is Co-Led by experts with complementary expertise in prevention implementation science
methods, research design, and quantitative, qualitative, and mixed methods analysis. Four workgroups will
carry out RMC's aims: (1) Implementation Evaluation & Measurement; (2) Biostatistics & Research Design; (3)
Qualitative & Mixed Methods; and (4) Health Economics. RMC will coordinate with the Administrative Core,
Career Enhancement Core, and Community Engagement Team to ensure methodologic support and rigor
across HC2 activities. RMC's contributions will generate critical methodologic advances towards reducing the
cancer mortality disparities experienced by individuals living in persistent poverty.